Empowering NMR Utilization in Mechanistic Biology: Extending Size Limits and Catalyzing Automation

Abstract
Nuclear Magnetic Resonance (NMR) has emerged as an essential tool for providing atomic-level insights into
the structure, interactions, and dynamics of proteins, offering a unique perspective beyond what is achievable
with de novo structure prediction programs, revealing domain orientations, alternate conformations, allosteric
mechanisms, and minor states, thereby significantly enriching our understanding of how proteins function under
near-native conditions. Despite its profound capabilities, NMR's broader application is limited by several factors
including sensitivity issues, especially in large proteins. The complexity of resonance assignment which becomes
increasingly challenging with larger proteins due to signal overlap, often requiring manual intervention despite
advances in automation. The necessity of long measurement times to achieve adequate signal averaging and
the significant expertise required to design and interpret NMR experiments, present a barrier that slows its
adoption for specific biological inquiries. In response to these challenges, this research proposal aims to expand
NMR's capabilities and streamline its workflow through a series of strategic innovations designed not only to
enhance the traditional uses of NMR but also to make it more accessible and efficient for non-specialists. These
innovations include the development of new methods that extend the size limits of observable systems, improve
sensitivity through advanced noise reduction techniques, and automate and optimize experimental setups.
Further, the introduction of innovative labels and probes and the development of new strategies for automated
resonance assignment are intended to integrate seamlessly with existing methodologies, thus enabling rapid,
reliable, and efficient NMR results. This approach includes leveraging machine learning for closed-loop
optimization in pulse sequence design, developing a universal denoiser for cleaning up NMR spectra, creating
adaptive, real-time sampling schedulers for multidimensional NMR experiments, reevaluating stochastic NMR
approaches using modern machine learning frameworks, and employing graph neural networks to better predict
chemical shifts by accurately capturing the local chemical environments of atoms. Additionally, the proposal
introduces novel labeling techniques which leverage the 19F-13C TROSY effects, local deuteration that restores
TROSY effect in eukaryotic expression systems and engineering specific bacterial gene knockouts to produce
clearer labelling profiles that are economic, and relaxation optimized. The proposal engineers a new platform
integrating NMR-based fragment screening with in silico screening methods to optimize drug discovery and
development. By addressing the existing limitations and bringing forward these technological and methodological
advances, the proposed research not only aims to democratize the use of NMR for a broader scientific
community but also seeks to provide deeper, more actionable insights into the complex dynamics and
interactions of proteins, thus potentially transforming our approach to mechanistic biomedical research and
therapeutic development.

Public health relevance
Project Narrative Nuclear Magnetic Resonance (NMR) provides unparalleled insights into the structures, dynamics, and interactions of proteins at atomic resolution, enhancing structural data from prediction programs by validating structures and revealing dynamic states and allosteric mechanisms. However, NMR's utility is limited by the need for specialized knowledge, extensive time commitments for both measurement and analysis, and restrictions on the size of observable systems. This research proposal aims to expand the capabilities of NMR technology by increasing the size limits of observable systems, enhancing sensitivity, automating data acquisition, and integrating these advancements to streamline workflows and democratize accessibility.